Effects of leptin in lipodystrophy independent of food intake

The primary aim of this study is to determine the energy intake-independent effects of leptin on energy metabolism in lipodystrophic subjects. The major aspects of energy metabolism to be studied are: 1. Lipid metabolism, including fasting lipids, lipolysis and fatty acid turnover, and ectopic lipid storage. 2. Glucose metabolism, including fasting glucose, endogenous glucose production, and insulin sensitivity 3. Energy expenditure, including total and resting energy expenditure, skeletal muscle work efficiency, and spontaneous physical activity In addition, the effects of leptin on endocrine and autonomic function will be examined, including effects on the thyroid, gonadal, and adrenal axes, as well as blood pressure, body temperature, and heart rate. During the past fiscal year, this study continued active recruitment, and has completed enrollment for subjects newly starting leptin. Enrollment for subjects withdrawing from leptin has reached 7 with a target of 10. This study has involved introducing several new or specialized human physiologic research techniques at the NIH Clinical Center, including hyperinsulinemic euglycemic clamps to measure insulin sensitivity, use of stable isotope tracer techniques to measure endogenous glucose and lipid turnover, magnetic resonance spectroscopy to measure liver and intramyocellular triglyceride, measurement of energy expenditure using indirect calorimetry, and pulse analysis of secretion of luteinizing hormone.